Transcriptional control by the epigenetic reader ENL in human cancer

PROJECT SUMMARY/ABSTRACT
An emerging hallmark of cancer is epigenetic alteration, which often results directly from somatic mutations of
genes encoding chromatin factors or secondarily from hyperactive signal transduction or metabolic changes.
These epigenetic changes in turn render cancer cells highly reliant on the chromatin machinery to maintain the
malignant state, thus creating opportunities for therapeutic intervention by targeting chromatin. Histone post-­
translational modifications (PTMs) carry an epigenetic layer of message that can be recognized and decoded by
dedicated protein “readers” to regulate fundamental DNA-­templated processes. Therefore, these recognition
events constitute key mechanisms underlying transcriptional control in cancer. We recently discovered that ENL,
a YEATS domain-­containing protein, acts as a novel reader for histone acetylation to regulate oncogenic gene
expression and is essential for the maintenance of a wide range of aggressive leukemia. Structural study
revealed an acetyl-­lysine binding pocket in the ENL YEATS domain that is amenable for drug targeting.
Furthermore, recurrent mutations in the ENL YEATS domain were recently reported in Wilms tumor, the most
common kidney tumor in children and associated with poor outcome, indicating a broad and important role of
ENL in cancer. The goal of this project is to fully elucidate the mechanisms by which ENL and its tumor-­
associated mutations establish and/or maintain the malignant state in cancer. During the mentored phase of the
award, the PI will apply innovative approaches to identify the combinatory histone codes and DNA-­binding factors
that determine the gene-­specific targeting of ENL (Aim 1). The PI will also identify and characterize effector
proteins that mediate the gene regulatory function of ENL in leukemia (Aim 2). During the independent phase,
the PI proposes to study the roles of tumor-­associated ENL YEATS mutations by testing the hypothesis that the
mutations confer gain of function in chromatin targeting and transcriptional control to drive the development of
Wilms tumors (Aim 3). Together, results from these studies will provide novel insights into epigenetic reader-­
mediated processes in cancer and advance the exploration of new therapeutic avenues for the associated cancer.
Under the guidance of an exceptional team of mentors, the PI will acquire new training in chromatin chemical
biology, computational epigenomics, and transcription regulation, which will critically contribute to the PI’s career
development and put her in a unique position to apply integrated approaches to reveal new insights into the
epigenetic control in cancer. The Rockefeller University and its neighboring institutions provide an outstanding
environment for the PI to carry out the proposed study and to enhance her professional development. The award
will serve as an ideal stepping stone for the PI to transition into an independence faculty position and to obtain
long-­term success in the field of cancer epigenetics.

Public health relevance
PROJECT NARRATIVE Investigating the chromatin decoding process by epigenetic reader proteins is essential not only to our basic understanding of epigenetic regulation, but also to the clinical exploration of epigenetic readers as a new class of therapeutic targets in cancer. Findings from the proposed study have great potential to pave the way to new treatment options for cancer such as aggressive leukemia and high- risk pediatric kidney cancer. The insights and the framework generated in this study will greatly benefit future investigation of other epigenetic regulators in additional cancer contexts.